Sex-Specific Effects of Endocrine Disruption on Aging and Alzheimer's Disease

OVERALL: SUMMARY/ABSTRACT Michelle M. Mielke, Ph.D.
Aging-associated physical and cognitive decline and Alzheimer's disease (AD) are conditions that affect men
and women differently across their lifespan. There are important sex and gender differences for these
conditions, including risk factors, manifestations, response to treatments, morbidity, and mortality. The
overarching theme of the Mayo Clinic Specialized Center of Research Excellence (SCORE) on Sex
Differences is to investigate how abrupt loss of ovarian hormones, caused by bilateral salpingo-oophorectomy
(BSO) prior to natural menopause, affects overall aging, physical and cognitive function, and risk for AD
pathophysiology. Given the large number of aging women with a history of premenopausal BSO, there is an
urgent need to understand the long-term physical and cognitive outcomes. In addition, we need new evidence
to empower women considering prophylactic BSO to make more informed decisions in the future. The central
hypothesis of our SCORE renewal is that the abrupt endocrine disruption caused by premenopausal BSO will
accelerate pathological aging processes that manifest as reductions in physical and cognitive function and in
AD pathophysiology. This hypothesis will be tested through three inter-related translational projects, which are
supported by three inter-dependent Cores. Our interdisciplinary translational approach using both humans
(Projects 1 and 2) and mice (Project 3) provides the foundation to: 1) establish the effects of abrupt endocrine
disruption in women, 2) develop a more complete understanding of the biological mechanisms involved, 3)
devise a targeted approach to identify and mitigate the adverse outcomes, 4) design future studies to
mechanistically test whether targeting senescent cells mitigates the effects of accelerated aging in these
women, and 5) empower women considering prophylactic BSO to make more informed decisions. Our rigorous
approach is supported by an experienced leadership team through the Leadership Administrative Core, by a
Resource Support Core - Clinical that will provide financial and operational efficiency for participant
recruitment, and by a Career Enhancement Core that will provide career enrichment, leadership training, and
funds to support ancillary studies of the main projects. These resources will stimulate new interest in sex
differences and women's health. The Mayo Clinic SCORE will serve as a vital hub for education and
dissemination of innovative sex-based translational research methods, results, and best practices. Our
integrated approach for research, training, and education is consistent with the goals of the SCORE on Sex
Differences RFA, and assures continuing research in areas of women's health and sex differences by training
the work force of the future.

Public health relevance
OVERALL: PROJECT NARRATIVE Michelle M. Mielke, Ph.D. The overarching theme of the Mayo Clinic Specialized Center of Research Excellence (SCORE) on Sex Differences is to investigate how the abrupt loss of ovarian hormones caused by bilateral salpingo- oophorectomy (BSO) prior to natural menopause affects overall aging, physical and cognitive function, and risk for Alzheimer's disease pathophysiology. Our interdisciplinary approach uses both humans and mice to establish the long-term effects of abrupt endocrine disruption, to develop a more complete understanding of the biological mechanisms involved, and to devise a targeted approach to identify and mitigate the adverse outcomes. Given the large number of aging women with a history of premenopausal BSO, there is an urgent need to understand the long-term physical and cognitive outcomes to empower women considering prophylactic BSO in the future to make more informed decisions.